Structural Dynamics at LCLS

ABSTRACT: COMMUNITY ENGAGEMENT
Community engagement is a strong focus of the proposed Resource, emphasized during all
aspects of the proposed BTRR activities through the Driving Biomedical Projects, Collaboration
and Services projects, workshops, a robust web presence, hands-on training and rapid
dissemination of results and capabilities. The Community Engagement goals are to involve the
research community throughout the Technology Research and Development process from initial
design and development strategies, testing and feedback, and training, with the ultimate goal to
provide the broadest possible access to Resource technologies bringing those technologies into
the community for use as quickly and effectively as possible. The proposed aspects of Training,
Collaborations, Service, and Dissemination work towards these goals.
The developed technologies will be made available to any and all users of the SSRL and LCLS
National User Facilities which will ensure a long-term sustainable access to the developed BTRR
capabilities. The access thus enabled will be complemented by reaching out to scientists who
could benefit from the developed technologies via conference attendance, workshop and remote
training as well as detailed website. This will ensure that access is provided to a qualified and
renewable community with challenging biomedical problems. Specific collaboration projects are
identified as an initial community of users who will benefit greatly from the proposed BTRR
developments and BTRR staff will work directly with these groups to ensure technologies are
robust for general use.
A continuous effort to evaluate and improve the community engagement tools will ensure the best
possible capabilities are provided to the broad biomedical scientific community.

Public health relevance
NARRATIVE: COMMUNITY ENGAGEMENT A narrative is not required for this component of the proposal.